Chronic outdoor air pollution, airway epithelial "omics" and asthma exacerbations in children

ABSTRACT:
Outdoor air pollution is a known cause of childhood asthma exacerbations yet is rarely addressed in routine
asthma care. This gap between scientific knowledge and clinical practice must be addressed to improve
healthcare for children with asthma. While there is no ‘safe’ level of pollution, personal susceptibility to both air
pollution and asthma exacerbations varies in children. Childhood asthma exacerbations are difficult to predict,
lead to missed school and parental work days, and contribute substantially to healthcare utilization and costs. It
is unclear if our current asthma therapies protect against pollution-induced exacerbations. Pollution reduction
policies are the best intervention, yet until such time as ‘clean’ air is guaranteed for all, developing biomarkers
identifying children at greatest risk of pollution-induced exacerbations are needed to develop interventions.
The airway epithelium is an ideal tissue to study omics and develop new biomarkers of pollution-induced
asthma exacerbations, as susceptibility genes for asthma are expressed in airway epithelium and pollutants
(e.g. particulate matter <2.5𝜇m (PM2.5)) induce epigenetic and gene expression changes. Little is known about
the effects of chronic pollution exposure on DNA methylation and gene expression in children with asthma, or
whether such changes are associated with asthma exacerbations. Further, it is unknown if pollution avoidance
recommendations (the Air Quality Index (AQI)) results in differential DNA methylation or gene expression. This
proposal will: 1) determine the association between exposure to PM2.5 and residential proximity to a major road
(a proxy for traffic-related air pollution) and (a) genome-wide DNA methylation and (b) gene expression in
nasal (airway) epithelium from children with asthma; 2) identify differentially DNA methylated markers or
expressed genes (by exposure level to PM2.5 or roadway) that are associated with asthma exacerbations; and
3) conduct an exploratory analysis to estimate the effects of the Environmental Protection Agency-sponsored
AQI behavioral intervention on DNA methylation and gene expression from a trial of children with asthma. Aims
1- 2 uses existing data from two completed NIH-funded studies. Aim 3 uses banked biospecimens from a pilot
randomized clinical trial of children receiving the AQI intervention on asthma action plans (i.e. clinical care).
This proposal addresses an unmet need, namely developing ‘omic’ markers of pollutant-induced asthma
exacerbations in children. Dr. Rosser’s career development plan provides for mastery of statistical genomic
methods and analyses, and builds upon clinical trial management and analysis skills. She is well positioned for
her proposed research given epidemiology background, skills with spatial modeling, and pilot data. This career
development award will provide the skills and preliminary data for an R01 seeking to test whether
epigenetic/gene markers predict risk of asthma outcomes and response to the AQI intervention.

Public health relevance
NARRATIVE: Although outdoor air pollution causes asthma attacks in children, healthcare providers caring for children with asthma lack proper tools to help prevent asthma attacks caused by air pollution. Identifying biomarkers that predict pollution-triggered asthma attacks will allow development of new therapies, thus providing healthcare providers with evidence-based interventions to help children with asthma better control their disease.